The Role of H3K79 Methylation and Dot1L in Neuronal Function and Neurodevelopmental Disorders

PROJECT SUMMARY
This proposal aims to identify the role of the histone lysine methyltransferase Dot1L in neuronal function and its
contribution to neurodevelopmental disorders (NDDs). NDDs include a spectrum of highly prevalent conditions
that manifest during development that can cause intellectual disability, developmental delays, and autism
spectrum disorder. Recent work demonstrated that many chromatin regulators are mutated in NDDs, including
the histone methyltransferase Dot1L. Dot1L methylates histone 3 of lysine 79 (H3K79me) which is associated
with active transcription. We found that H3K79me is highly abundant and dynamically regulated in postmitotic
neurons. Our preliminary data also indicate that H3K79me is critical for neuronal function. We found that patient
mutations result in a loss of Dot1L methyltransferase activity indicating that depletion of H3K79me can cause
NDDs. Further, we found that Dot1L depletion alters transcription of synaptic genes and bidirectionally regulates
GluA2, an AMPA receptor subunit. Finally, we found long-term memory deficits in Dot1L conditional knockout
(cKO) mice. However, the role of Dot1L in neuronal function and cognition remain unclear. I hypothesize that
Dot1L regulates synaptic gene expression and that partial Dot1L loss disrupts this regulation leading to NDDs.
In Aim 1, I will define chromatin and transcriptional disruptions caused by partial Dot1L loss using a heterozygous
Dot1L cKO mouse model coupled with H3K79me2 cleavage under targets and tagmentation (CUT&Tag) and
RNA-sequencing. In Aim 2, I will examine the impact of partial Dot1L loss on neuronal function and cognition by
using the heterozygous Dot1L cKO mouse model and controls to perform electrophysiology and behavioral
experiments. Cumulatively, this work will establish a role for Dot1L in neuronal function and NDDs and more
broadly will contribute to understanding of the role of chromatin regulators in brain function.

Public health relevance
PROJECT NARRATIVE Chromatin regulators are disproportionately mutated in individuals with neurodevelopmental disorders. Dot1L, a methyltransferase, is one such protein in which patients with monoallelic de novo mutations solely in Dot1L have deficits such as global developmental delay. This proposal aims to examine Dot1L’s contribution to transcriptional regulation in the brain and Dot1L’s impact on neuronal function and behavior with hopes to provide insights into a broader understanding of chromatin regulators role in brain function and neurodevelopmental disorders.